Catestatin regulation of tauopathy and its therapeutic potentials

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is a neurodegenerative disease characterized by the progressive decline of memory
and cognitive functions associated with neuronal loss. Formation of extracellular amyloid beta (Ab) plaques
containing insoluble b-amyloid, intracellular neurofibrillary tangles (NFTs) composed of hyperphosphorylated
Tau, and microglial dysfunction leading to neuroinflammation are the major hallmarks of AD. The existing FDA
approved drugs offer limited effects on cognitive improvement and AD remains inexorable and incurable.
Therefore, there is an urgent need for novel discoveries on therapeutic targets.
Chromogranin A (CgA) is overexpressed in AD and Corticobasal Degeneration (CBD) frontal cortices as
well as in cortex of 9-month-old PS19 mice. In contrast, Catestatin (CST: hCgA352-372), a pleiotropic peptide
derived from CgA, is significantly reduced in primary (CBD and PSP, Progressive Supranuclear Palsy) and
secondary (AD) Tauopathy brains as well as in PS19 brain. Using mini-mental state examination score, we found
that a low concentration of CST is associated with the worst prognosis in both AD cortex and hippocampus. CST
also caused decreased phosphorylation of Tau and Tau aggregation in vivo in PS19 mice as well as decreased
seeding in organotypic slice culture. In addition, CST caused decreased activation of hippocampal microglia
coupled with decreased concentration of inflammatory chemokines/cytokines in PS19 brain (cortex).
Furthermore, we found exposure of CST in PS19 brain after intraperitoneal and subcutaneous administration of
CST, indicating that the above effects of CST in PS19 mice are indeed direct effects.
We have developed three specific aims to fulfil our hypotheses. Aim I: Determine CST-induced
amelioration of Tauopathy phenotypes. Although our preliminary results are convincing and statistically
powered, in this aim, we will (i) test dose-dependent effects of CST in improvement in behavioral and cognitive
deficits in PS19 mice (pro-active and reactive cohort), (ii) evaluate dose-dependent effects of CST on
neurofibrillary tangles (NFTs), synapse, synaptic vesicles, and mitochondrial health; and (iii) dose-dependent
effects on phosphorylation of Tau. Aim II: Determine the mechanisms underlying CST-induced amelioration
of Tauopathy. In this aim, we will (i) run RNA Seq analyses to assess CST-induced differentially expressed
genes in PS19 brain (cortex and hippocampus); (ii) examine whether CST ameliorates Tauopathy by reducing
neuroinflammation in PS19 brain and in primary microglia cells. (iii) evaluate whether CST inhibited
catecholamine secretion is one of the mechanisms of action. Aim III: Evaluate the ADMET (Absorption,
Distribution, Metabolism, Excretion, and Toxicology) properties of CST. These studies will be performed in
collaboration with Dr. Daniel B. Kassel, Founder & CEO, SciAnalytical Strategies, Inc. San Diego, CA.
Impact: Successful completion of the proposed studies will help determine if CST can be developed as a
potential therapy against the multifactorial disease AD/Tauopathy.

Public health relevance
Project Narrative Currently, 6.2 million Americans aged 65 and older suffer from dementia (memory loss) due to Alzheimer's disease, which incurred $355 billions of US health care expenditures in 2021. Since no disease-modifying treatments are currently available for Alzheimer's disease, there is a substantial unmet clinical need for effective treatments of this disease. Given the pro-cholinergic, anti-inflammatory, and neuroprotective effects of the Chromogranin A derived peptide Catestatin (CST), the studies proposed may prove the concept that an endogenous peptide CST has therapeutic potentials for a novel drug for Alzheimer's disease and the associated dementia.